Integrated Genomics and Bioinformatics

Integrated Genomics & Bioinformatics Core: Project Summary/Abstract
Modern cancer research relies on a broad array of genome-wide approaches. The mission of the Koch Institute
Integrated Genomics & Bioinformatics Core (IGB Core) is to support the acquisition of genomic and gene
expression data and the organization and analyses of the resulting large and complex data sets through
advanced technology service platforms, state-of-the-art computational infrastructure and expert bioinformatics
capabilities. It provides Center Members with integrated and comprehensive services including consultative
services and training in experimental design and data analyses and technical pipelines from sample generation
and quality control to sequencing and informatic analysis to allow investigation of: mRNA, microRNA and lncRNA
expression; splicing events; transcription factor binding sites; epigenetic modifications; point mutations and
chromosomal abnormalities; and single cell genomics. In the prior renewal, the Genomics and Bioinformatics
Cores were presented as separate entities. We have now combined these into the IGB Core, reflecting the critical
importance of integrating genomics data generation with downstream informatic analysis. The IGB Core is an
Institutional Shared Resource between the Koch Institute and three other MIT units.
During the current period, usage of the IGB Core increased from 80% to 87% of Center Members. To support
this demand, the IGB Core expanded sample preparation, quality control and processing, data analysis, and
hardware and software capabilities. This includes expanded offerings for ii) sequencing library preparation,
including development of multiple high-throughput (HT) protocols; ii) single cell acquisition/sequencing and
analysis approaches; iii) long read sequencing services and analysis; and iv) RNAseq and Epigenomics analysis
capabilities. The IGB Core also deployed new compute and data storage resources. Core staff provided
additional direct support to this CCSG through development of financial and publication database and client-side
interfaces. Thus, this Shared Resource is essential to the success of the Koch Institute mission.
In the upcoming period, The IGB Core is committed to continued enhancement of genomics technologies and
informatics expertise as well as maintaining IT hardware to support these efforts and the KI research community.
Planned initiatives include: developing additional HT methods for sequencing library preparation; further
strengthening expertise in single cell genomics applications; expanding data storage and compute cluster and/or
cloud computing in line with investigator needs; and expanding informatics training offerings to include more
hands-on workshop opportunities. This shared Core is of exceptional value to the CCSG because Koch Institute
Members account for 47% of the Genomic services usage and 87% of Informatics services usage, but the CCSG
contribution to the Core (8%) is comparable to that of the other sponsoring entities (7%) and far less than the
costs covered by user chargebacks (78%).